tRNA fragments and their role in tau pathology in Alzheimer's disease and tauopathies

Project Summary
Alzheimer’s disease (AD) and related dementias (ADRD) pose significant challenges with a growing societal
impact. Addressing these challenges requires comprehensive research into the neurobiology of the diseases,
leading to innovative biomedical concepts, approaches, and molecular targets. A central factor in these
disorders is the protein tau, whose misregulated homeostasis, aggregation, and intercellular spread contribute
to AD, Frontotemporal dementia (FTD), and other tauopathies. Tau-containing neurofibrillary tangles (NFTs)
from AD brains are known to contain RNA, and it is proposed that tau-RNA interactions may facilitate tau
aggregation and modulate neuronal vulnerability to stress. However, the specific RNA species involved in tau
pathology remain unidentified. Our data suggest a novel class of small RNA transcripts—tRNA-derived
fragments (tRFs)—that accumulate in AD, potentially binding tau and promoting its misfolding and
aggregation. Regulated by disease-related neuronal stress, tRFs are enriched in extracellular spaces and
body fluids, including cerebrospinal fluid (CSF), and can be taken up by recipient neurons. Our research aims
to investigate the role of specific tRFs in tau aggregation, pathology propagation, and neurodegeneration in
ADRD through the following Specific Aims. Specific Aim 1: Characterize the small RNA landscape, with a
focus on tRFs, at different stages of AD pathology using an optimized RNA sequencing platform. Examine
the RNA binding capacity of intracellular and extracellular tau variants and mutants using human induced
pluripotent stem cell (iPSC)-derived neurons and rodent primary neurons. Identify tRFs within pathological
tau aggregates and visualize their colocalization with tau pathology in human AD brains. Specific Aim 2:
Investigate the impact of selected tRFs and tRF-enriched extracellular complexes on tau homeostasis and
pathology using gain- and loss-of-function approaches in neuronal cell models. Specific Aim 3: Examine the
effects of specific tRFs on tau pathology and behavioral phenotypes in WT mice and a humanized Tau
P301S/PS19 mouse model of tauopathy and neurodegeneration. Assess neuroprotective effects of targeting
specific tRFs in the brain. This collaborative R01 project seeks to unravel the complex molecular mechanisms
underlying ADRD and explore the cellular and extracellular biology of these disorders. Findings may reveal a
new class of potential therapeutic targets and biomarkers.

Public health relevance
Project Narrative Addressing Alzheimer's disease and related neurodegenerative diseases requires innovative molecular targets, concepts, and treatment approaches. This R01 project aims to explore the cellular and extracellular biology of stress-induced non-coding RNAs and their involvement in tau pathology and propagation. The research holds the potential to significantly enhance our understanding of Alzheimer's disease and may pave the way for novel therapeutic interventions.